North American Star Consortium

North American Star Consortium (NASC) (CA-UM186644) is consisted of Princess Margaret Cancer Centre-
University Health Network (PM-UHN) as its Lead Academic Organization (LAO) and 5 Affiliated
Organizations (AOs): H. Lee Moffitt Cancer Center, Virginal Commonwealth University, University of Texas
Southwestern, Northwestern University and The State University of New Jersey at Rutgers. In the first
two years of its UM1 grant, NASC has exceeded its accrual target of 100 patients per year by 38
participants. This administrative supplement enables the additional funding per participant for this over-
accrual.

Public health relevance
North American Star Consortium (NASC) (CA-UM186644) is consisted of Princess Margaret Cancer Centre- University Health Network (PM-UHN) as its Lead Academic Organization (LAO) and 5 Affiliated Organizations (AOs): H. Lee Moffitt Cancer Center, Virginal Commonwealth University, University of Texas Southwestern, Northwestern University and The State University of New Jersey at Rutgers. In the first two years of its UM1 grant, NASC has exceeded its accrual target of 100 patients per year by 38 participants. This administrative supplement enables the additional funding per participant for this over- accrual. Per case costs: These costs do not include patient clinical care costs which would be expected to be covered by insurance or third-party payors for research subjects. Based on experience with ongoing early phase clinical trials, it is estimated that research-related direct costs (not covered by insurance or third- party payors) will average approximately $4,274 USD/patient. This amount will also cover biospecimen collection for correlative analyses as part of ETCTN clinical trials. The additional funding supported via this Administrative Supplement will be distributed to the LAO and AO sites based on the relative accrual efforts during the first two years of this UM1 grant.